Investigating how chemotherapeutic thiopurines inhibit telomerase elongation of telomeres

Project Summary/ Abstract
Telomere maintenance at chromosome ends is essential for the growth of cancer cells. In humans, telomeres
end in a single strand overhang consisting of GGTTAG repeats that form the substrate for telomerase.
Telomerase is a reverse transcriptase composed of two subunits: a protein component (TERT) and an RNA
component (TR) which contains an integral template used to reverse transcribe multiple telomeric repeats
during a single telomere binding event. Telomerase is an attractive target for cancer therapies because it is
expressed in over 85% of cancer cells, while most adult somatic cells lack telomerase. Thiopurines are a class
of nucleoside analogs used to treat leukemia and some pediatric cancers but are highly toxic. The prodrug 6-
thio-2'-deoxyguanosine (6-thio-dG) was developed to reduce non-specific thiopurine toxicity. This drug was
shown to successfully reduce the growth of mouse tumor xenografts for multiple cancer types. 6-thio-dG
treatment can also cause telomere shortening and dysfunction, however, the mechanism was unknown until
recently. In biochemistry experiments, I discovered that human telomerase can readily add the 6-thio-dG
metabolite, 6-thio-dGTP, to a growing telomere chain, but this insertion then strongly inhibits telomerase’s
ability to add additional telomeric repeats. I found that POT1-TPP1, which normally enhances telomerase
binding and the addition of multiple repeats, cannot restore telomere elongation in the presence of 6-thio-
dGTP. In addition, 6-thio-dGTP has a low micromolar IC50 for human telomerase due to telomerase’s inability
to discriminate between dGTP and 6-thio-dGTP but does not inhibit DNA polymerase progression, reducing its
off-target impact. My preliminary data for this project demonstrate that 6-thio-dG can disrupt telomerase
binding when the modified base is located at the 3’ end of the telomeric overhang. I hypothesize that 6-thio-dG
addition impairs telomerase’s interaction with the telomere, thereby disrupting cycling for repeat addition
synthesis and inhibiting telomerase elongation of telomeres in cells. I will use complementary biochemical,
single-molecule, and cellular approaches to test my hypothesis. Aim 1 will elucidate the mechanism by which
6-thio-dG disrupts the telomerase catalytic cycle. Aim 2 will determine whether telomerase can synthesize
DNA and extend telomeres in cancer cells treated with 6-thio-dG. Aim 3 will determine if 6-thio-dG efficacy in
cancer cells is enhanced by inhibiting the thiopurine sanitase, NUDT15.
Completing this project will improve our understanding of how 6-thio-dG impacts telomerase activity and
telomere maintenance in cancer cells. It will also enhance our understanding of how 6-thio-dGTP nucleotide
impacts telomerase catalysis and its potential utility as a therapeutic for halting cancer cell proliferation. This
fellowship will allow me to acquire new skills related to the project’s aims and outlines specific mentors for
each. Career development is also a strong focus in this fellowship, which includes plans to attend workshops
related to experimental techniques, data analysis, and scientific writing and attend national and international
conferences to present the findings of this research project. This fellowship will help me acquire the training
necessary to become an independent investigator.

Public health relevance
Project Narrative Telomerase is a prime target for cancer therapeutics since it is expressed in over 85% of cancers and enables unlimited cell division, but is lacking in most non-cancerous cells. This fellowship will investigate how the chemotherapeutic thiopurine, 6-thio-dG, inhibits telomerase’s ability to restore telomeres, causing telomere shortening and cellular growth arrest, and whether inhibiting thiopurine sanitase can improve 6-thio-dG efficacy. This study will provide mechanistic insight on how 6-thio-dG inhibits telomerase and halts cancer cell proliferation, which can inform future basic and clinical research studies.